Investigation of Medical Management to Prevent Episodes of Diverticulitis (IMPEDE) Trial

ABSTRACT
This application proposes a pilot feasibility randomized trial of the USDA Healthy Mediterranean-style Food
Pattern versus standardized guidance on fiber intake for patients with diverticulitis in response to PAS-20-160,
Small R01s for Clinical Trials Targeting Diseases within the Mission of NIDDK. Diverticulitis is one of the most
common gastrointestinal indications for inpatient hospital admission, outpatient clinic and emergency room visits,
and colon surgery. At least 20% of individuals with an initial episode of diverticulitis will have one or more painful
and unpredictable recurrences. Unfortunately, there is no proven pharmacologic means to decrease the risk of
diverticulitis. Large, prospective, observational studies have identified diet and lifestyle risk factors for incident
diverticulitis. In one study, men who adhered to a low-risk profile (< 51g/day red meat, >23g/day fiber, 2 hours
exercise/week, normal BMI, and never smoked) were 75% less likely to develop incident diverticulitis. However,
these modifiable risk factors have not been evaluated for secondary prevention. Studies of diet and plasma
inflammatory markers suggest that chronic, systemic inflammation is a potential mechanism that underlies the
dietary effects on diverticulitis development. The Mediterranean diet pattern is comparable to diets associated
with primary prevention of diverticulitis, is more strongly associated with reduced inflammation, and is familiar to
providers and many patients. Thus, we propose to conduct a randomized trial (n=75) of a USDA Healthy Med-
style Food Pattern versus standardized guidance on fiber intake for patients with diverticulitis to evaluate the
feasibility of this dietary intervention including willingness to randomize and adherence to a Med-style dietary
pattern. We will employ state-of-the-art behavioral interventions in the form of electronic feedback to improve
health-related behaviors and support dietary customization based on participant’s budget, dietary preferences,
and restrictions. We will also examine plasma inflammatory biomarkers (interleukin-6, interleukin-10, and
interleukin-1β) and fecal calprotectin at baseline, 6, and 12 months. The proposed feasibility trial will set the
groundwork for a large multicenter RCT of a food pattern–behavioral intervention versus standardized guidance
on fiber intake in patients with a history of diverticulitis. It will also expand our knowledge of inflammation and
diverticulitis pathogenesis and gather prospectively collected samples for future biomarker study. Ultimately,
given the prevalence and morbidity of diverticulitis and the lack of predictive and preventative measures,
identifying a proven means of secondary prevention and a biomarker of risk would change treatment paradigms
and improve the lives of millions of patients with diverticulitis.

Public health relevance
Project Narrative Diverticulitis is a common gastrointestinal indication for hospital admission, outpatient visits, and colon surgery in the U.S. We propose a randomized trial of a USDA Healthy Mediterranean-style Food Pattern versus standardized guidance on fiber intake for patients with diverticulitis to determine feasibility of a larger-scale effectiveness trial focused on the clinical outcome of recurrent diverticulitis; furthermore, we will examine plasma and fecal inflammatory biomarkers. Identifying a candidate intervention for secondary prevention and a biomarker of risk would have profound impacts on management and improve the lives of millions of patients with diverticulitis.